Papillomavirus Bioinformatics Resource

The PapillomaVirus Episteme (PaVE) has been established to provide information and bioinformatics resources to the scientific community for research on the Papillomaviridae family of viruses. The PaVE consists of a relational database and web applications that support the storage, annotation, analysis, and exchange of information. PAVE can be found at http://pave.niaid.nih.gov
PaVe contains genomic and protein sequences for all papillomaviruses. It includes a multiple sequence alignment tool, a protein structure viewer, a viral typing tool and an Image viewer for visualizing clinical manifestations of viral infection. Linked review articles provided detailed information about all aspects of functional genomics of papillomaviruses.

In FY2025, the PaVE database and website was updated to contain 853 annotated papillomavirus genomes (including 254 Non-reference genomes), 11338 genes and regions, 6687 protein sequences, and 108 protein structures, which users can explore, analyze or download.

This resource is invaluable for the papillomavirus research community. To date, PaVE has been cited 932 times on Google Scholar and has users in over 150 countries around the world. In FY2025, PaVE consistently has between 100 and 150 users per day.

PaVE is especially important for data reproducibility and rigor, as all researchers are working with identical information sources.